Class II Human Leukocyte Antigen biologics for antibody-mediated graft rejection.

PROJECT SUMMARY/ABSTRACT
The mission of Antiger Therapeutics Inc. is to develop novel immunotherapies for transplant recipients to
improve long-term graft outcomes and minimize adverse effects. Antibody-mediated rejection (AMR) is a
leading cause of graft loss, with over 3000 new cases per year in the United States and estimated market size
of $90 million. However, this estimate is likely to underestimate the market potential as currently no FDA-
approved drugs or treatments are available for AMR. Donor-specific antibodies (DSA) against class II human
leukocyte antigens (HLA) are the most frequent driver of AMR, which was reported in 68-91% of AMR after
kidney, heart, or lung transplants. Current therapies, such as plasma exchange and inhibition of all B cells or
plasma cells, have not demonstrated benefits for patients with AMR in randomized clinical trials. These
therapies also non-selectively suppress the immune system and increase the risk of severe infections. To
address these unmet needs, this SBIR will explore antigen-specific depletion of DSA-producing cells as a
novel approach to AMR treatment. In our preliminary work, we generated class I HLA fusion proteins that
potently and selectively depleted class I HLA-specific target cells in vitro and in vivo. This work motivated us to
develop targeted immunotherapies for AMR caused by class II DSA. The product of this SBIR will be a soluble
class II HLA biologic, capable of depleting a unique and more precise therapeutic target—B cells producing
antibodies against the specific class II HLA expressed on the graft. The technical innovation of this product is
the structure-based engineering of class II HLA to stabilize a high-risk antigen in AMR for production and
clinical translation. The product will be among the first-in-class biologics to enable antigen-specific
immunotherapy on the AMR market, with the potential of prolonging the graft survival and preserving the rest
of the humoral immunity for infection control. We hypothesize that functional class II HLA biologics can be
efficiently produced through two distinct engineering approaches, and these biologics should demonstrate
selective cytotoxicity against B cell hybridomas of the corresponding specificity. In Specific Aim 1, we will
generate a monovalent class II HLA biologic to deplete specific antibody-producing B cell hybridomas. In
Specific Aim 2, we will create a bivalent class II HLA biologic to deplete target cells. By the end of this phase I
SBIR, we expect to generate one or more candidate proteins with high production yield, purity, and selective
cytotoxicity against target cells to meet pre-specified acceptance criteria. We will further demonstrate the
efficacy and safety of these candidates in vivo in a phase II SBIR and then pursue licensing the product to a
pharmaceutical partner for development toward FDA approval. The ultimate therapy, as a result of this project,
will shift the paradigm in AMR treatment to antigen-specific immunosuppression with unprecedented precision.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE STATEMENT Antibody-mediated rejection (AMR) has been recognized as a leading cause of graft failure among transplant recipients and is associated with high mortality rates and increased healthcare costs. Through this SBIR funding, we will develop a novel biologic therapy with antigen-specific precision to remove the root cause of most AMR cases and prolong graft function. The ultimate product of this project should improve the well-being, quality of life, and survival of transplant recipients while reducing the infection risk and need for re- transplantation and organ demand.